BIOINSTRUMENTATION LAB: FACULTY: EM, HPLC, UV VIS SPECTROPHOTOMETER

The bioinstrumentation laboratory facility consists of a centralized instrument laboratory, and the electron microscopy facility. The centralized instrument laboratory contains major equipment for support of the various research projects in biomedical sciences. This laboratory houses the HPLC, UV-Vis spectrophotometer, gas chromatographs, electrophoresis apparatus, and other basic instruments for conducting research in the Health Research Center. The spacious laboratory will house all major equipment that will be acquired through RCMI funding.